Continuation of the UIC Chronic Renal Insufficiency Cohort Clinical Center

From 2003 to 2008, the prospective Chronic Renal Insufficiency Cohort (CRIC) Study enrolled 3,939 adults
with chronic kidney disease (CKD) to address overarching goals of identifying predictors of rapid progression
of kidney disease and clarifying the relationship between kidney dysfunction and the risks of subclinical and
clinical cardiovascular events, death, and resource utilization. During the last funding period (2013-2018),
CRIC continued to follow the cohort and recruited an additional 1,465 individuals with milder CKD. The study
has been successful in publishing over 150 articles, promoting young investigative careers, establishing an
active ancillary study program, and fostering international collaborations. The next phase of the study, which
extends follow-up through 2023, will afford a unique opportunity to focus on two content areas of particular
importance to the understanding and, ultimately, the treatment of CKD: 1) the investigation of non-linear
trajectories of renal function using in-home serum creatinine and urine protein testing systems, and 2) the
identification of cardiovascular sub-phenotypes detected using ambulatory noninvasive biosensors. The study
will evaluate these two novel measures as both exposures and outcomes. This application is submitted in
response to RFA-DK-17-508, “Limited Competition: Continuation of the Chronic Renal Insufficiency Cohort
(CRIC) Study (U01)” on behalf of the University of Illinois at Chicago (UIC) Clinical Center. During the first
three phases of the CRIC Study, the UIC Clinical Center research team has been successful in terms of
recruitment, retention, protocol implementation, data quality, and scientific productivity. Noteworthy
achievements at UIC have included a strong focus on heath disparities in CKD, a significant number of UIC
investigator-led publications, leadership on funded-ancillary studies (i.e., two R01s, two K23s, one K24, and
four Diversity Supplements), and the promotion of new physician-scientists.

Public health relevance
The prospective Chronic Renal Insufficiency Cohort (CRIC) Study enrolled more than 5000 adults with chronic kidney disease (CKD) to address overarching goals of identifying predictors of rapid progression of kidney disease and clarifying the relationship between kidney disease and the risks of cardiovascular events, death, and resource utilization. This proposal for the next phase of the CRIC, which extends follow-up through 2023, will provide a unique opportunity to focus on two areas of particular importance to the understanding of CKD: 1) the investigation of non-linear longitudinal changes of kidney function using in-home testing systems, and 2) the identification of patterns of cardiovascular disease using wearable devices. During the first three phases of CRIC, the UIC Clinical Center research team has been successful in terms of recruitment, retention, protocol implementation, data quality, a strong focus on heath disparities in CKD, scientific productivity, and the promotion of new physician-scientists.